IGF::OT::IGF OTHER FUNCTIONS. Use of Target Trial Approach for Addressing Selection Biases in SEER Treatment Assignment Data. Period of Performance 9/20/17 - 9/19/18.

Use of Target Trial Approach for Addressing Selection Biases in SEER Treatment Assignment Data